CALCIUM, PHOSPHORUS AND BONE METABOLISM IN CHILDREN RECEIVING HOME PARENTERAL

The influence of parenteral nutrition on bone mineralization and metabolism was evaluated. Four children, partially ad fully dependent on parenteral nutrition were evaluated over 24 hours with dietary assessments, and timed urine and blood collections. Mediators of calcium and bone metabolism were monitored.